Development of a nanoparticle-based gene editing technology for neurological applications

Abstract
This supplement proposal focuses on investigating if CRISPR Cas9 ribonucleoproteins (RNPs) complexed to
cell-penetrating peptides (CPPs) can rescue mice from Huntington’s disease, using the R6/2 mouse model.
These experiments are based upon our recent studies demonstrating that CPPs can efficiently transfect CRISPR
Cas9-RNPs neurons in the striatum after an intracranial injection using convection enhanced delivery (CED).
We have selected the 2/6 mouse model for these studies because this model has recently been rescued with
Cas9 based genome editing, using AAV delivered SaCas9. In this proposal we will build on our Preliminary
Studies and will inject Cas9-RNP complexed to CPPs into the striatum and thalamus, via CED, and will
investigate if we can edit the huntingtin (HTT) gene to rescue mice from Huntington’s disease. If successful,
these experiments will identify the levels of genome editing needed in the brain to generate therapeutic outcomes
in the Huntington’s animal model.

Public health relevance
Narrative The purpose of this project is to apply our previously developed gene editing technology to an animal model of a brain disease. Specifically, we are testing the ability of a new formulation of our gene-editing monoparticles to disable the mutant gene that causes Huntington’s disease (HD) in a mouse model. By the end of this project, we hope to show that our approach is a valid path for transition into the clinic for the eventual treatment of HD in humans.